CORE--BIOSTATISTICS CORE

The purpose of the Administration and Biostatistics Core is to provide efficient overall management of the Center, including fiscal management of the Research Projects, to provide biostatistical consultation services, and to assist in secretarial and office support services. This Core provides administrative support for all Center activities such as the seminar series, makes arrangements for visiting scientists and trainees, and assists with preparation of scientific talks and publications.